NHIS Cancer Control Supplement: Cancer Questions on the 2022 National Health Interview Survey

Pertaining to the National Health Interview Survey in general and cancer questions specifically, this agreement pays a portion of all costs associated with the implementation of the NHIS including questions on cancer.